Shared Resource 13: Health Communication

Health Communication Shared Resource Project Summary / Abstract The Health Communication Core provides expert consultation and a full range of professional creative services, delivering cost-efficiency and added value to DF/HCC investigators. The centralized resource offers complete communication-related consultation and professional creative services to support DF/HCC investigators who are applying for external grant funding, implementing interventions, recruiting study subjects, or disseminating research findings. As a result, DF/HCC researchers have easy access to such state-of-the-art services as development, production, and testing of communication material as well as consultation with experts in health communication and behavioral sciences.

Public health relevance
Project Narrative Not applicable.